Feasibility Trial of a Novel Integrated Mindfulness and Acupuncture Program to Improve Outcomes after Spine Surgery (I-MASS)

ABSTRACT
Spine pain consistently ranks first or near the top in global rankings of disease burden, and epidemiological
data suggest the burden is worsening. The number of low back surgeries has increased by 300% over the past
2 decades, accounting for approximately 30% of spine-related costs in the US. While it can provide cost-
effective pain relief to some patients, up to 25% of those who undergo spine surgery will develop persistent
pain requiring additional surgery, imaging, or other invasive interventions. Moreover, many patients will
experience persistent opioid use, which carries significant risks of misuse, addiction, and overdose. Clinical
practice guidelines strongly recommend the use of multimodal – or ‘mind and body’ – treatments for effective
pain management after surgery. This approach combines interventions with analgesic or physical therapeutic
inputs alongside interventions with psychological or behavioral inputs to better address the multifaceted risk
factors for persistent pain and opioid use following surgery. Integration of Mindfulness delivered via mobile app
(mHealth) with auricular Acupuncture (AA) in individuals undergoing Spine Surgery (I-MASS) is a highly
promising multimodal treatment approach given the distinct yet complementary mechanisms by which
mindfulness and AA influence pain after surgery. Establishing the effectiveness of I-MASS requires a
rigorously designed pragmatic trial comparing it to usual medical care in adults who undergo spine surgery.
However, trials of this size and scope require careful preparation. This proposed mixed methods R34 project is
designed to answer important preparatory questions regarding the feasibility and acceptability of I-MASS
through the following Specific Aims: 1) Conduct interviews with patient and care delivery stakeholders to refine
and finalize the I-MASS intervention protocol by integrating mHealth mindfulness training and AA for use in
patients age 18-80 undergoing spine surgery; 2) Conduct a single-site, exploratory randomized controlled
clinical trial to assess the feasibility and acceptability of I-MASS in patients undergoing single-level
laminectomy, discectomy or fusion; and 3) Use feasibility trial results to develop and submit a competitive
research proposal to NIH for a multi-site, pragmatic, randomized comparative effectiveness clinical trial
designed to rigorously evaluate I-MASS compared to mHealth mindfulness, AA, and usual care augmented
with standard education. The results of this R34 project will provide the information needed to successfully
execute on such a study and create new knowledge regarding the feasibility and acceptability of a highly
innovative non-pharmacological multimodal approach designed to improve the lives of patients undergoing
spine surgery.

Public health relevance
PROJECT NARRATIVE Mindfulness and acupuncture are non-pharmacologic interventions that can effectively address postsurgical pain and reliance on opioids, however the size of their effects is small. Given their distinct yet complementary therapeutic targets, integrating mindfulness and acupuncture into a combined program has strong potential for additive or even synergistic effects that could substantially reduce risk for persistent pain and opioid use following surgery. The purpose of the proposed R34 project is to assess the feasibility and acceptability of an integrated program that combines mindfulness delivered via mobile app (mHealth) with auricular acupuncture in individuals undergoing spine surgery (I-MASS) in preparation for a fully powered, pragmatic, randomized comparative effectiveness trial.